ANALYSIS OF PHOSPHOPEPTIDES FOR ZEE-YONG

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Zee-Yong Park, a colleague from when I was in the Yates lab sent me two files to put through our analysis workflow. These files are from the enrichment of phosphopeptides by IMAC.